NDRGs as mediators of hypoxia adaptation

PROJECT SUMMARY
Oxygen is essential for the life of many organisms, as it used during aerobic respiration to generate cellular
energy in the form of adenosine triphosphate (ATP). Low oxygen (whether caused by environmental or cellular
hypoxia) prevents adequate ATP production and can consequently cause cell death. Paradoxically, excessive
oxygen, which often occurs post-hypoxia, is equally damaging, due to a surge in reactive oxygen species
(ROS) that is damaging to biomolecules. Hence, aerobic organisms such as humans are susceptible to
fluctuations in oxygen levels, which is manifested in many disease states, including chronic kidney disease,
acute kidney injury, sickle cell anemia and stroke. Stroke alone was the 5th leading cause of death in the US in
2017. Thus, an understanding of how cells can adapt to changes in environmental oxygen under different
circumstances, and how this response can be manipulated therapeutically, is a major challenge for improving
human health. Despite the pathology caused by low O2, evolutionarily conserved mechanisms exist that
protect organisms from hypoxic injury. One such mechanism is metabolic suppression, which involves the
downregulation of energy-demanding processes to match reduced ATP production. The signaling pathways
that trigger and maintain metabolic suppression are mostly unknown. The Brewster laboratory recently
uncovered a novel role for the adapter protein N-myc Downstream Regulated Gene 1a (Ndrg1a) in promoting
long-term adaptation to anoxia (zero oxygen) in the zebrafish embryo via metabolic suppression. The specific
aims of this proposal are to deepen our mechanistic understanding of how Ndrg1 functions. Specifically, we
will: (1) Uncover how Ndrg1 regulates trafficking of the sodium-potassium ATP-ase (NKA) pump in response to
anoxia and re-oxygenation; (2) Investigate the broader function of Ndrg1a and Ndrg3a in hypoxia adaptation;
(3) Determine whether lactate is necessary and sufficient to prime cells for anoxia survival.
In addition to these research goals, the PI will leverage the University of Maryland Baltimore County's
outstanding commitment to Inclusive Excellence and her own position as the Director of the Graduate
Research Training Initiative for Student Enhancement (G-RISE) Program to enhance the recruitment and
retention of PhD students from historically underrepresented (HUR) groups at UMBC and will train HUR
students at all levels in hypoxia research in her laboratory. These students will be an integral part of her
research group; will work on independent projects and author publications.

Public health relevance
PROJECT NARRATIVE Aeorobic organisms are highly susceptible to fluctuations in oxygen levels, which is manifested in many disease states. This project aims to investigate an endogenous signaling pathway that reduces metabolic rate and enable cells to withstand longer periods without oxygen. The ability to manipulate these pathways in human cells has significant therapeutic implications for the prevention of hypoxic injury that occurs in many disease states (e.g. pulmonary vascular disease, acute kidney injury, diabetes and neurodegenerative diseases).